Research Education Component

The WF OAIC Research Education Component (REC) seeks to foster talented researchers’ independence
in a challenging academic environment, and to support the development of the translational skills needed to
conduct multi-disciplinary research consonant with the WF OAIC theme, “Integrating pathways affecting
physical function for new approaches to disability treatment and prevention.”
Led by national research leaders, Drs. Denise Houston and Heidi Klepin, the WF OAIC REC recruits promising
and diverse early-career faculty and creates an individualized career development plan for each REC Scholar’s
needs based on prior education, experience, strengths and weaknesses, and personal goals. The plans
include: a) a well-designed research project, integrated with the OAIC’s theme, to initiate an independent line of
research; b) a formal, individualized educational and skill acquisition plan with exposure across the translational
spectrum and opportunities for leadership, ethical and administrative development; c) a robust team-based
mentorship program to foster translational approaches; and d) a rigorous monitoring process using specific
milestones of achievements.
The Specific Aims of the WF OAIC REC are: 1) to recruit, support, and mentor early career faculty (REC
Scholars) with a demonstrated commitment to an aging research career by providing financial support and a
tailored mentorship, research and educational program emphasizing the development of skills and
competencies necessary to build an independent career in collaborative and interdisciplinary aging research;
and 2) to monitor progress of REC Scholars using specific milestones of expected achievements, and improve
REC programs through an on-going evaluation process. Formative and summative evaluations encompassing
REC activities, interactions with other OAIC components, and interactions with university-wide career
development activities will be used to improve and refine REC-sponsored activities.
In this cycle, we are proposing to implement four new or enhanced activities that build upon our previous
successful innovations or are in response to evaluative feedback from previous or current scholars: 1)
Translational Catalyst Meetings; 2) Research Design Studios; 3) Virtual Cross-OAIC Scholar Spotlight Series;
and a 4) Geriatric Assessment Boot Camp. Through its programs and activities, the WF OAIC REC trains
interdisciplinary scientists in team-based collaborative approaches in order to discover, evaluate, and translate
innovative approaches to preserve function and prevent and treat disability.